Development of novel methods to enable robust comparison of real-world Progression Free Survival (rwPFS) and Clinical Trial PFS in Multiple Myeloma

Project Summary
In multiple myeloma (MM), real-world evidence (RWE) has been successfully used in the post-approval
setting to characterize real-world efficacy and provide important safety information. Recent legislation
aimed at advancing RWE to support drug development has created opportunities for considering RWE in
pre-approval regulatory decision-making.1 Despite these efforts, RWE has been unimpactful in the pre-
approval MM setting. In the ABECMA memo, the FDA stated the accompanying RWE study was
inconclusive because of measurement bias in real-world Progression Free Survival (rwPFS) limited
comparisons to trial data.2 We propose to develop novel methods for comparing rwPFS and trial PFS
in MM.
The measurement bias that limits comparison of rwPFS and trial PFS can be disaggregated into
misclassification bias & surveillance bias. We will address each of these biases as follows:
AIM 1: Develop novel methods to correct for misclassification bias of IMWG response criteria
among (a) all real-world MM patients and in (b) historically under-represented MM patients
• Characterize real-world patterns of missingness in assays collected for MM disease assessment
per the International Myeloma Working Group (IMWG) response criteria3
• Replicate real-world patterns of missingness in IMWG response criteria in the control arms (CA) of
3 Janssen trials & quantify the effect of this missingness on progression (miscPROG)
• Test likelihood-based and weighting methods to correct misclassification bias through simulation.
AIM 2: Develop novel methods to correct for surveillance bias in disease assessment among (a) all
real-world MM patients and in (b) historically under-represented MM patients
• Characterize the real-world cadence(s) of MM disease assessment
• Replicate real-world cadence(s) in CA of 3 Janssen trials & quantify the effect on PFS (survPFS)
• Develop surveillance bias correction methods through simulations
AIM 3: Validate all bias correction methods developed in AIM 1 & 2 in holdout RWD and compare to
the control arms from at least two other Janssen MM trials
• Assess comparison of trial CA PFS to bias-corrected and trial-emulated RWD CA PFS
Janssen will work closely with renowned academic methods experts, MM researchers and Flatiron
Health, a private sector leader in MM RWD, to complete this research (please see ‘Consortium
Agreement and Key Personnel’). We intend to make these novel methods available through peer-reviewed
publications. This research is fully aligned with Janssen’s Credo and our first responsibility to serve the
needs of patients.

Public health relevance
Project Narrative In multiple myeloma (MM), real-world evidence (RWE) has been successfully used for real-world comparative effectiveness and other on-market research. In contrast, the FDA has found RWE to be less impactful for pre-approval regulatory decision-making in MM because measurement bias limits comparisons of real-world progression free survival (rwPFS) to clinical trial PFS. We propose to work with renowned academic methods experts, leading MM researchers & Flatiron Health to develop novel methods for comparing rwPFS and trial PFS to support the use of RWE in pre-approval regulatory decision-making.